Center for Alcohol Research in Epigenetics

Project Summary:
Alcohol use disorder (AUD) can be characterized by a pattern of compulsive alcohol drinking and development
of several withdrawal symptoms that promote relapse and maintenance of addiction. Long-term alcohol use
causes molecular, structural, and functional changes in key brain regions such as medial prefrontal cortex (mPFC),
hippocampus, amygdala, and ventral tegmental area (VTA) which may drive behavioral phenotypes, such as
anxiety, depression, panic, pain, deficits in cognition and reduced reward sensitivity. Several studies have shown
that protein families such as histone deacetylases (HDACs), histone acetyltransferases (HATs), histone
methyltransferases (HMTs), DNA methyltransferases (DNMTs), and lysine demethylases are important players
in epigenetic and transcriptional changes during withdrawal after chronic ethanol exposure. However, the cell-
type specificity of the interplay between epigenetic mechanisms (open chromatin accessibility) and the
transcriptomic changes that occur across brain regions [prelimbic mPFC, central nucleus of amygdala (CeA),
dorsal hippocampus, and VTA] which eventually leads to the development and maintenance of AUD is not well
known. The overall aim of this Alcohol Research Center is to evaluate the cellular heterogeneity of
transcriptomic and epigenomic changes leading to structural and electrophysiological changes in
specific brain regions that underlie withdrawal behavioral phenotypes in AUD. This renewal P50 application
entitled “Center for Alcohol Research in Epigenetics (CARE)” consists of four highly inter-related preclinical and
translational research projects [research project #1, VTA, (Brodie /Grayson), research project #2, Amygdala,
(Pandey/Sparta), research project #3, Hippocampus, (McMurray/ Krishnan) and research project #4, mPFC,
(Glover/Auta)] and two Cores [Administrative (Pandey/ Brodie), and Epigenetics Core (Grayson/Maienschein-
Cline/Gao/Boergens/Krishnan)] utilizing animal models of AUD and human postmortem brain regions of AUD
subjects. In addition, the CARE will continue to serve as an important resource and provide a scientifically
enriched environment for training opportunities for the next generation of alcohol researchers and will
disseminate scientific knowledge of AUD to the general public through a community outreach program. The
primary thematic focus of CARE as a whole will be to causally link emerging cell type-specific mechanisms
identified by 10x genomics (snRNA-seq and snATAC-seq) in the proposed brain circuitry to several behavioral
phenotypes of AUD during withdrawal. Mechanistic approaches (CRISPR-dCas9 or shRNA) will be used to
manipulate the cell type-specific epigenome through alterations of either histone acetylation/methylation
mechanisms or DNA methylation mechanisms, in key brain circuitry that regulates behavioral phenotypes
associated with AUD (anxiety, depression, panic, pain, cognition deficits and reduced reward sensitivity) in order
to better understand the pathophysiology of AUD and develop better pharmacotherapy.

Public health relevance
Project Narrative: Alcohol use disorder (AUD) is a major public health concern worldwide. The proposed 10x genomics along with mechanistic approaches to investigate cellular heterogeneity of transcriptomic and epigenomic changes underlying structural and functional changes in key brain regions will lead to the identification of novel mechanistic insights into several ethanol withdrawal symptoms of AUD. The potential new epigenetic targets identified in specific cell types will enable us to develop drugs for the treatment and prevention of AUD.